User Training and Outreach

Abstract – User Training and Outreach
It is imperative that the users of ALS-ENABLE have the training and information necessary to immediately and
effectively use the mature synchrotron technologies of the Resource. The User Training and Outreach
component of the ALS-ENABLE Resource ensures that individual broad-based training provides a strong basis
for users on the operations and best practices of data collection at ALS-ENABLE beamlines. Safety is of the
utmost importance and begins before beamtime is scheduled: users are required to complete the ALS
Experimental Safety Assessment Form (ESAF) describing their samples and the presence of any toxic or
hazardous materials which is then reviewed by the beamline scientist and the ALS Biological Safety Officer. Prior
to beamtime users receive training from the ALS on the proper use of PPE, cryogen handling, emergency
procedures, storage and safe use of chemicals, and laboratory safety (if applicable). At the beamline, staff
provide on the job training on the safe, efficient use of beamline hardware. Additionally, a multifaceted approach
that incorporates face-to-face onsite training, the use of online and remote materials, and group training is used
to help users achieve their goals. Workshops and seminars will train large groups at once and our unique
“reverse” synchrotron trip provides training at the NIH user’s home institution. Outreach activities are a
fundamental component of informing the scientific community of the capabilities, availability, and modes of
access to the ALS-ENABLE Resource. We will continue to publish results in peer-reviewed journals, participate
in and host meetings and workshops, and strive to reach out to under-represented communities to promote the
Resource, recruit new users, and engage the structural biology community. Specific efforts will be made to
engage and recruit projects from scientists that may not use structural biology as their main technique. A robust
web presence (als-enable.lbl.gov) supports these efforts and provides access to all beamline manuals, training
materials, scientific highlights, and descriptions of the technologies available in the different ALS-ENABLE cores.